Regulation of Gap Junction Coupling During Development and Neuronal Injury

Abstract section was revised to reflect changes in Specific Aims (see above). As a result, the description of Specific Aims #2 and #3 is not included in the revised abstract.

Public health relevance
Project Narrative This study is relevant to public health. It addresses the mechanisms of regulation of neuronal gap junctions (electrical synapses) during development and traumatic brain injury and the role of gap junctions in traumatic brain injury. This research may have clinical importance given that gap junction coupling increases during brain injury, but the mechanisms of increase and the role of neuronal gap junctions in traumatic brain injury are not yet understood.